HEALTH SERVICES RESEARCH CONFERENCE SUPPORT

The purpose of this contract is to provide partial support to the Association for Health Services Research for the planning, development, and convening of two annual national conferences on Health Services Research.